Tuning Adipocyte Size and Obesity through SWELL1

Project Summary
Healthy adipose tissue expansion is necessary for maintaining metabolic health in the setting of over-nutrition –
a situation that is increasingly relevant in the US, as the incidence of obesity is estimated at 33% of the US
population. Therefore, elucidating the fundamental nutrient sensing mechanisms that regulate adipocyte
expansion is critical for understanding, and ultimately treating, the negative metabolic consequences of obesity.
We previously identified Leucine Rich Repeat Containing 8A (LRRC8a or SWELL1), a newly discovered
essential component of the volume-regulated anion channel (VRAC), as a novel volume-sensing regulator of
both insulin sensitivity and insulin secretion. We and others find that SWELL1 activity and protein expression is
reduced in metabolically unhealthy obese mice and humans – suggesting that reduced multi-organ SWELL1
activity/expression contributes to obesity-induced metabolic syndrome. Our group has biochemical, patch-
clamp and imaging evidence that SWELL1 channel complexes are also expressed and functional in
lysosomes. Given that lysosomes are signaling hubs that integrate nutrient sensing and AKT-mTOR signaling,
we hypothesize that lysosomal SWELL1-LRRC8 channels participate in cellular nutrient sensing by
activating in response to increases in intraluminal lysosomal leucine, and that this signaling mechanism
is dysregulated in the setting of obesity-induced diabetes and insulin resistance. To test this hypothesis,
we combine unique reagents and innovative methods from the Diwan (lysosomal signaling), Xu (lysosomal
patch-clamp), and Held (mass spectrometry) laboratories, with our expertise in SWELL1 signaling, and access
to human adipose tissue samples from highly phenotyped metabolically healthy and unhealthy humans (Klein
laboratory). Our objective is to understand the mechanisms of plasma membrane and lysosomal SWELL1 (Lyso-
SWELL1) nutrient sensing and how it is dysregulated in disease states, including obesity-induced glucose
intolerance and insulin resistance. The rationale for these studies is that delineating the contribution of SWELL1
to lysosomal nutrient sensing and mTORC1 activation will advance our understanding of a fundamental cellular
signaling mechanism and guide innovative therapeutic approaches for patients with prediabetes and diabetes.
We propose the following AIMs:
· AIM#1: Delineate the mechanisms of plasma membrane versus lysosomal SWELL1 signaling to AKT-
AMPK-mTOR signaling in adipocytes
· AIM#2: Examine the contribution of SWELL1 signaling in vivo in the setting of obesity in mice and
humans
The knowledge gained from these studies will delineate a novel lysosomal ion channel signaling pathway that
regulates adipocyte growth and systemic dysglycemia in obesity, and inform therapeutic strategies currently
underway to modulate SWELL1 signaling for the treatment of obesity-induced metabolic syndrome.

Public health relevance
Project Narrative Diabetes and associated diseases are major health concerns in today’s society. The proposed research is relevant to the mission of the NIDDK because it examines a novel molecular mechanism of SWELL1 signaling in obesity-induced Type 2 diabetes. Exploring this novel pathway and intracellular signaling mechanism will expand our understanding of innovative therapeutic avenues for the treatment and prevention of obesity-induced diabetes.